SAFTINet: Optimizing Value and Achieving Sustainability

DESCRIPTION (provided by applicant): This proposal capitalizes on the tremendous progress made in the initial 3 years of the Scalable Architecture for Federated Translational Inquiries Network (SAFTINet) project and strategically plans for a sustainable technical infrastructure and engaged user community that supports comparative effectiveness research (CER), patient-centered outcomes research (PCOR), clinical and quality improvement initiatives, and informs health policy decisions. SAFTINet is a distributed research network (DRN) dedicated to addressing questions relevant to minority, poor, and disadvantaged populations. This project brings together key safety-net stakeholders to inform technologic and network enhancements. Stakeholder will identify high value data uses and create a strategic sustainability plan. We will enhance the ability to link claims and clinic data to support CER/PCOR and other data uses, and assess the ability of our system to meet stakeholder needs.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project seeks to enhance the capabilities of an existing data network, the Scalable Architecture for Federated Translational Inquiries Network (SAFTINet), by improving its ability to answer impactful questions about the best health care treatments and the best way to provide health care, with special emphasis on the poor and disadvantaged. For this project, we will bring together a diverse set of stakeholders with different perspectives regarding health care (e.g., providers, patients, payer, policy experts, etc.,) to inform enhancements to the data network and plan for sustainability.